Characterizing the role of MARCH5 in apoptosis regulation in acute myeloid leukemia

Project Summary
Acute myeloid leukemia (AML) remains a devastating illness, with a clear need for the development of novel
anti-leukemic therapy. Inhibition of anti-apoptotic BCL2 family proteins to directly stimulate apoptosis provides a
feasible therapeutic strategy for treating AML. Venetoclax, a BCL2-specific inhibitor, has exhibited promising
anti-leukemic effect in a subset of patients with AML. However, resistance to venetoclax can develop. Therefore,
identification of other synergistic targets attacking the apoptosis defense system is needed to enhance the
efficacy of anti-BCL2 therapy in AML. Integrating functional genomics and xenograft models, I developed an in
vivo CRISPR-Cas9 screen approach to identify MARCH5, a RING-type ubiquitin E3 ligase, as an essential gene
for AML cell growth. My preliminary studies showed that MARCH5 is a critical regulator of apoptosis in AML cells.
MARCH5-depleted AML cells display increased apoptotic cell death and enhanced sensitivity to venetoclax,
suggesting that MARCH5 can serve as a potential therapeutic target for AML. The goal of this proposal is to
evaluate the translational potential of targeting MARCH5 as an AML therapy, and investigate the mechanism of
action of MARCH5 protein and its related network to provide biological insights for the development of therapeutic
strategies targeting MARCH5. The Specific Aims are: (1) Determine the domains of the MARCH5 protein critical
for preventing apoptosis in AML; (2) Evaluate the therapeutic potential of MARCH5 inhibition in preclinical models
of AML; and (3) Identify the key regulatory proteins critical for MARCH5-mediated apoptosis regulation. This
study will deepen our understanding of the apoptosis regulation and its clinical application in AML, uncover novel
therapeutic opportunities for targeting MARCH5 and AML, and provide a synergistic approach to enhance the
efficacy of venetoclax in AML and potentially other malignancies.
I am a postdoctoral research fellow in the laboratory of Dr. Kimberly Stegmaier at the Department of Pediatric
Oncology at Dana-Farber Cancer Institute (DFCI). My current research focuses on identification and
characterization novel dependencies in acute leukemia, and the application of these knowledge to the
development of novel therapeutic approaches. My long-term career goal is to establish a research program
focusing on understanding the molecular mechanisms of leukemogenesis and leukemia vulnerabilities, with a
strong commitment to translate basic scientific discoveries into the clinic. The proposed research will form a solid
platform from which I can establish my own research group by the end of the K99 Award period. I have developed
a focused training plan to accomplish my goal: (1) expand my scientific knowledge and vision; (2) sharpen my
critical thinking and technical skills; and (3) develop and strengthen my professional skills. With the mentorship
of Dr. Kimberly Stegmaier, deep support from my scientific advisory committee, and rich resource and
collaborative environment offered by DFCI and the Harvard community, I will be well prepared for the transition
into the independence.

Public health relevance
Project Narrative Acute myeloid leukemia (AML) remains a devastating illness, with a clear need for the development of novel anti-leukemic therapy. This proposal will characterize the molecular mechanism of MARCH5 protein and its interactome in regulating apoptosis, and evaluate the translational potential of MARCH5 inhibition as an AML therapy and a synergistic approach to enhance the efficacy of venetoclax. This study will reveal novel insights of apoptosis regulation in AML, and provide biological basis for the development of strategies targeting MARCH5 to benefit patients with AML.